The role of cholesterol metabolic enzyme CYP46A1 and its metabolite 24S-hydroxycholesterol in ischemic stroke.

PROJECT SUMMARY
The overall objectives for this application are to determine the role of cholesterol metabolic
enzyme CYP46A1 and its metabolite 24S-hydroxycholesterol (24S-HC) in ischemic stroke. Our
central hypothesis is that activation of CYP46A1 results in increased production of 24S-HC,
which contributes to ischemic brain injury through potentiation of NMDAR. To test our
hypothesis, we will use a combination of in vitro and in vivo stroke models along with
electrophysiology, calcium imaging and transgenic mice to pursue the following three specific
aims: Aim 1. Determine the role of CYP46A1 in ischemic brain injury; Aim 2. Determine the role
and molecular mechanism of 24S-HC in ischemic neuronal injury in vitro; Aim 3. Define the
signaling cascade underlying the role of CYP46A1 in ischemic brain injury. Success of the
proposed research will define the role of cholesterol metabolic enzyme CYP46A1 and its
metabolite 24S-HC in ischemic brain injury.

Public health relevance
PROJECT NARRATIVE The proposed research will disclose a new mechanism and signaling cascade that have critical impact on stroke outcome: CYP46A1 → 24S-HC → NMDAR → ischemic brain injury. This is expected to be a significant contribution because it will expand our knowledge of the mechanism of ischemic brain injury. Additionally, it validates and identifies new targets for stoke intervention, e.g., CYP46A1 and those allosteric modulatory sites on NMDAR that are critical for the binding of 24S-HC.